Targeted prostanoid inhibition as an anti-inflammatory therapy for diabetic retinopathy

PROJECT SUMMARY
Diabetic retinopathy (DR), a microvascular complication of diabetes, is the leading cause of irreversible vision
loss in working-age Americans. As the number of Americans with diabetes continues to climb, the prevalence
of DR is expected to rise in coordination. Current therapies for DR treat only late stages of disease after
irreparable damage to the retina has occurred, highlighting the need for therapeutic interventions to prevent
early-stage progression. Since the 1960s, it has been hypothesized that retinal inflammation may drive early
DR progression in a cyclooxygenase (COX)-dependent manner. However, trials of various nonsteroidal anti-
inflammatory drugs (NSAIDs) to inhibit COX as a DR treatment have failed in large part due to severe
cardiovascular or gastrointestinal side effects associated with chronic, broad-spectrum COX inhibition by these
drugs. Alternatively, targeting specific prostanoids—the lipid signaling molecules downstream of COX—and/or
their receptors could offer a therapeutic approach that isolates anti-inflammatory benefits while avoiding the
severe side effects of NSAIDs. Five prostanoids are generated in the COX pathway, signaling through nine
prostanoid receptors. The goal of the research proposed here is to determine the therapeutic potential of
inhibiting individual prostanoid signaling to slow DR onset and progression. My preliminary studies have
identified that two of the five prostanoids—PGE2 and PGF2α—are elevated in primary human retinal cells
cultured in conditions of dyslipidemia or inflammation relevant to diabetes. PGE2 is elevated in Müller glia, cells
responsible for maintaining homeostasis in the retina, and PGF2α is elevated in retinal microvascular
endothelial cells, which form retinal blood vessels. I hypothesize that these two prostanoids are critical drivers
of proinflammatory cytokine production and leukostasis, hallmark pathologies associated with DR. This
proposal expands upon these findings to define the landscape of retinal prostanoid elevation under conditions
relevant to systemic diabetes and to determine the preclinical efficacy of small molecule prostanoid receptor
antagonists as targeted therapeutic strategies against DR progression. I propose utilizing primary human
cultures of Müller glia and retinal microvascular endothelial cells as well as a diabetic mouse model to
interrogate antagonism of prostanoid signaling in both cell- and animal-based disease-relevant experimental
models. In completing these studies, I aim to characterize a novel therapeutic strategy to precisely target
molecular signaling pathways that may drive retinal vascular inflammation in early-stage DR before irreversible
damage occurs. I will carry out my work in the supportive mentoring environment of Dr. John Penn’s laboratory
at Vanderbilt University, an institute with rich support of both prostanoid and vision research and with a long
history of exemplary graduate training. The training plan outlined in this proposal, paired with my research
goals, will aid invaluably in my training to become an independent academic research scientist.

Public health relevance
PROJECT NARRATIVE Diabetic retinopathy, the leading cause of blindness in working-age Americans, currently lacks therapies that target early stages of disease before severe damage to the retina has occurred. NSAID drugs such as ibuprofen have exhibited some capacity to limit the retinal inflammation that occurs early in diabetic retinopathy, but chronic use of these drugs can cause severe side effects that outweigh any benefits. I propose to identify the specific receptor(s) of prostanoids, the lipid signaling molecules downstream of NSAID targets, that can be inhibited by small molecules to prevent inflammation in the retina, identifying a novel therapeutic option for diabetic retinopathy that acts before vision loss begins.